Therapeutic potential of targeting glia as an inflammatory mediator source and bacterial reservoir

ABSTRACT
Bacterial infections of the central nervous system (CNS) are associated with a high
degree of mortality and serious neurological deficits. While inflammation is often a
crucial component in host defense against infectious organisms, such responses can
have devastating consequences in the CNS and astrocytes and microglia play a major
role in the initiation and propagation of bacteria-associated neuroinflammation.
Furthermore, bacteria pathogens, including Borrelia burgdorferi, can invade and persist
in glia. Bacteria sequestered intracellularly may exacerbate glial inflammatory
responses and provide a reservoir for chronic infections. As such, developing novel
treatment strategies that can limit both intracellular CNS bacterial burden and glia-driven
neuroinflammation is of considerable importance. In this exploratory and developmental
R21 project, we will employ a novel non-immunostimulatory nucleic acid-based linear
nano-scaffold, developed by our research team, combined with an appropriate carrier
molecule, to deliver an anti-inflammatory therapeutic nucleic acid cargo and/or an anti-
microbial agent into resident CNS cells and assess its therapeutic benefits following
direct administration of B. burgdorferi into the CNS. These nanoparticles will be
functionalized to target the master inflammatory gene transcription regulator NF-kB with
RNAi and decoy DNA oligonucleotides, or be co-functionalized with the antimicrobial
agent LL-37 to limit bacterial burden and associated neuroinflammation. The successful
attenuation of neuroinflammation or bacterial burden with such functionalized
nanoparticle-carrier formulations will support the therapeutic potential of targeting glial
cells as a source of inflammatory mediators, or as a bacterial reservoir, to limit
neurological damage and/or extend the effective window for antibiotic treatment during
bacterial CNS infections.

Public health relevance
PROJECT NARRATIVE Glial cells play a major role in the initiation and propagation of the detrimental immune responses associated with bacterial infections of the CNS and may provide a reservoir for recalcitrant infections. As such, developing novel treatment strategies that can limit both central nervous system bacterial burden and glia-driven inflammatory damage could be of considerable importance. In this exploratory and developmental R21 project, we will employ novel nucleic acid nanoparticle technology to attenuate glial immune responses and introduce an intracellular anti-microbial agent to test the therapeutic potential of this approach following in vivo bacterial challenge of the CNS.